Perineuronal nets, hippocampal plasticity, and autism spectrum disorder.

Project Summary
Autism Spectrum Disorder (ASD) is a heterogeneous group of neurodevelopmental conditions, which often
present with social recognition dysfunction. Phelan-McDermid syndrome and Fragile X syndrome, two
monogenic causes of ASD, have social recognition deficits, such as difficulty recognizing familiar faces, emotions
on faces, and familiar voices. Transgenic mouse models based on genes known to be mutated in Phelan-
McDermid (SHANK3) and Fragile X (FMR1) display deficits in social recognition during development as well as
in adulthood. The CA2 region of the hippocampus has been identified as a key brain region in social recognition
function both during development and in adulthood. Both Shank3B and Fmr1 KO mice have atypical perineuronal
nets (PNNs), extracellular matrix structures known to regulate plasticity, in the CA2 region of the developing
hippocampus. Normalizing CA2 PNNs in Shank3B and Fmr1 KO mice can restore social recognition function,
and some evidence suggests that PNN correction may be most effective if it occurs during a sensitive period of
development. In other systems, PNNs play a role in connectivity development by sequestering molecules like
semaphorin-3A (sema3A), which is known to provide guidance cues to axons and to inhibit synapse elimination.
The supramammillary nucleus (SuM) of the hypothalamus projects to the CA2 region, a circuit that is known to
contribute to social novelty detection and social discrimination in adulthood. In the CA2 region, SuM axons
release substance P (SP), a neuropeptide known to enhance neuronal activity. SuM afferents, as well as SP
receptors, are abnormal in the CA2 of Shank3B and Fmr1 KO mice although it remains unknown whether SP
signaling contributes to social recognition. The broad, long-term objectives of this proposal are to investigate
potential roles for PNNs and sema3A in the development of SuM-CA2 structure and function in healthy, as well
as Shank3B and Fmr1 KO mice. More specifically, we will use pharmacological and viral manipulations of
PNNs, sema3A, and SP signaling, chemogenetic manipulations of neuronal activity, lipophilic dye and
immunolabeling for dendritic spines, synaptic markers, and immediate early gene expression, in
vivo electrophysiology, and behavioral analyses in wildtype mice and transgenic mice with social dysfunction.
These approaches will be used to probe potential mechanisms of healthy CA2 development, and to test
targets of intervention for correcting function both during development and in adulthood. Taken together, the
findings of the proposed experiments will advance our understanding of how PNNs and sema3A affect SuM-
CA2 structure and function during development, and whether SP signaling can be harnessed to restore CA2
function in adulthood in genetic mouse models for ASD.

Public health relevance
PROJECT NARRATIVE: Autism spectrum disorder (ASD) is a set of neurodevelopmental conditions often associated with social recognition deficits. Understanding the involvement of perineuronal nets, semaphorin 3A, and substance P in social recognition in healthy and genetic mouse models related to ASD may provide clues for the creation of new therapies to restore function in development and adulthood.